Administrative Core

Strong and effective leadership is required for promotion of new and innovative science, and is critical
to forging the new scientific and community partnerships needed to address emerging research challenges in
HIV/AIDS prevention, treatment, and care. The Core draws on a multi-disciplinary team of senior researchers
and administrators to set, implement, and evaluate the HIV Center’s scientific agenda and ensure efficient
administrative and fiscal coordination of our domestic and international research projects. The Core serves as
the hub for Center activities and coordination across the Cores and as a liaison between the Center and
internal and external affiliated entities that inform and collaborate in our research agenda. Through the Admin
Core, Center Leadership maintains our focus on the theme, “Reducing HIV and Mental Health Disparities to
End the HIV Epidemic,” and our emphasis on research at the intersection of behavioral, social, biomedical,
and implementation science. The Core has three Specific Aims: (1) To provide timely and innovative scientific
and programmatic leadership and governance that positions the HIV Center as a local, national, and
international resource; (2) to ensure synergy and scientific rigor of the HIV Center and Cores in meeting
the Center’s goals; and (3) to provide centralized administration and coordination of fiscal and
organizational management of HIV Center Cores and affiliated research projects.
We will accomplish our Aims through a range of mechanisms that include (1) internal monitoring of day-
to-day operations and Cores’ and investigators’ progress, through ongoing Center and Core leadership
meetings; (2) working with several external groups to support the Center in evaluating and updating short-term
and long-term strategic planning goals, including (a) our Institutional Advisory Group (IAG), comprising senior
CU scientists with HIV expertise in various disciplines who are leaders of Centers, Training Programs, and
other major University entities, (b) four Community Advisory Groups, in collaboration with the NYC and NYS
Departments of Health, (c) our mandated Scientific Advisors, and (d) our innovative Performance and Safety
Monitoring Board; (3) supporting a range of communication and dissemination activities, including (a)
maintaining a dynamic re-designed Website; (b) providing technical support for listservs and web-based
conferencing; (c) distributing a monthly electronic newsletter; and (4) providing administrative and fiscal
management for all grant-related activities. The Administrative Core will be led by current Center Director
Robert H. Remien, Ph.D., a Professor of Clinical Medical Psychology in Psychiatry at Columbia University,
supported by current Center Co-Directors Claude Ann Mellins, Ph.D., a Professor of Clinical Psychology in the
Departments of Psychiatry and Sociomedical Sciences at Columbia University, and Gina Wingood, Sc.D.,
M.P.H., a Professor of Public Health Promotion in Sociomedical Sciences at the CU MSPH; and Masud
Rahman, M.S., M.B.A., current Center Director of Finance and Administration.